IGF::OT::IGF: Informatics Support for NIDA. September 23, 2017 - September 22, 2018. N01DA-17-8940.

The purpose of this task order is to obtain Contractor support to assist in the general maintenance, engineering, system, and database development lifecycle activities managed by NIDA DTMC. Key objectives of this task order include: 1. Provide continuous applications programming and support for the various Java, ColdFusion, and .NET/C# based applications managed by the NIDA DTMC including, but not limited to: Addiction Treatment Development Team Information Management System (AIMS), NIDA Datashare, Serious Adverse Event Tracking and Reporting System (SAETRS), and Opentext Content Server. 2. Support enhancement or upgrade of functionality in response to demands that arise from DHHS, NIH, NIDA, Chief Information Officer (CIO)/ Office of the CIO (OCIO) mandates (initiatives/requirements/mandatory policies etc.). 3. Compliance with NIDA's Software Configuration and Change Control Management (SCCCM) processes and conformance with DHHS mandated Enterprise Performance Life Cycle (EPLC) Framework. 4. Business consulting, stakeholder management, training and communications (i.e. Job and Navigational Aids, Instructor-Led Training to NIDA personnel, pertaining to NIDA application functionality.